COVID-19 RELATED STUDY INVOLVING DOGS

Human recombinant ACE2 will be administered to dogs as an aerosol to assess potential toxicities. Results will be used to support an Investigational New Drug Application with the FDA for a clinical trial addressing patients with COVID-19 infection.